Acquisition of Quant Studio 5 as replacement of aging thermocycler for diagnostic testing

Project Abstract
The Wisconsin Veterinary Diagnostic Laboratory (WVDL) has participated in sample
analysis for the FDA Vet-LIRN, either for surveillance, during an animal food/drug emergency
outbreak or during a large-scale animal food/drug emergency event for surge capacity. During
the past years, we have implemented culture for Salmonella from dog feed and feces, culture of
Listeria from animal feed, culture and direct Campylobacter jejuni PCR from dog feces. We had
also investigated in E. coli carbapenem-resistant gene PCR assay. Additionally, we have
participated in several investigations with Vet-LIRN or our human health partners including
necropsy of a cat infected with SARS-CoV-2 and C. jejuni isolation from a dog consuming a raw
meat diet. We have been very active in supporting SARS-CoV-2 PCR testing of exposed
animals from positive households with real-time PCR as an integral part of these testing efforts.
The WVDL continue to develop and validate new PCR assays to meet testing need for both
large and small animals. For companion animals testing, we worked very closely with the UW
shelter medicine program in responding to various disease outbreak in shelters across the
country. The specific request for this proposal is to replace an aging ABI 7500 Fast
thermocycler with a newer model of Quant Studio 5 to aid WVDL in maintaining our capacity in
molecular testing and critical response to animal food/drug emergency or disease outbreak. As
a Vet-LIRN laboratory, we are always stand ready to response to these emergency testing
needs.

Public health relevance
Project Narrative The WVDL is an integral member of the Veterinary Laboratory Investigation and Response Network (Vet-LIRN) and the National Animal Laboratory Health Network (NAHLN). Our laboratory provides diagnostic testing for disease investigation during peacetime and during an animal food/drug emergency or disease outbreak. Having functional and reliable equipment will ensure our capacity to respond to animal food/drug emergency or disease outbreaks.